Peripheral Sympathetic Dysfunction in Cardiac Disease

Project Summary
Myocardial infarction and heart failure increase risk for ventricular arrhythmias and sudden cardiac death.
Autonomic dysregulation and sympathetic hyperactivity accompany these diseases and trigger lethal
arrhythmias. Interventions that target the central nervous system to inhibit sympathetic outflow have not been
effective in patients, but interventions that target the peripheral sympathetic nervous system decrease
arrhythmias and prolong life. We hypothesize that central nervous system activity is amplified by post-
ganglionic neurons in cardiovascular disease to enhance norepinephrine and neuropeptide Y release at the
heart, which contributes to pathology. We have discovered excitatory collaterals between sympathetic post-
ganglionic neurons that foster synchronous amplification of preganglionic signals. We hypothesize that
disease-induced changes in the heart trigger morphological and electrical transformation of sympathetic
postganglionic neurons that results in sympathetic hyperactivity. To identify the mechanisms responsible for
hyper-sympathetic changes, we exploit transgenic mouse models coupled with neurochemistry, single cell
RNAseq, patch clamp electrophysiology, retrograde tracing and 3D reconstruction of labeled neurons to link
structure with function. We will connect neural function to norepinephrine and neuropeptide Y release in the
heart. The combined power of single cell synaptic measures with mouse genetics and retrograde tracing offers
unique opportunities to resolve mechanisms responsible for augmented transmission specific to cardiac
projecting neurons. We will test the hypotheses that myocardial infarction and heart failure drive increased
cardiac sympathetic transmission: through expanding dendritic arbors and their synaptic inputs (Aim 1);
through enhancing neuronal activity (Aim 2); and through altering neuronal calcium handling (Aim 3). We have
assembled a unique team of accomplished experts, key animal models, and powerful genetic tools to
accomplish these studies. We expect that novel insights and targets for therapeutic intervention will come from
the studies described here, and that this work with have implications for treatment of the many diseases
characterized by high sympathetic activation.

Public health relevance
Project Narrative Patients with myocardial infarction and heart failure have a high risk for cardiac arrhythmia and sudden cardiac death. Both conditions are characterized by increased cardiac sympathetic transmission, and sympathetic hyperactivity can trigger lethal arrhythmias. The goal of our research is to elucidate the mechanisms that underlie enhanced peripheral sympathetic transmission to the heart in cardiovascular disease. This will lay the groundwork for new therapeutic options that target the nervous system to decrease arrhythmia risk and prevent sudden cardiac death.